AUTONOMIC REGULATION AND EXERCISE TRAINING IN OLDER INDIVIDUALS

This study will examine the role of catecholamines, catachamine metabolism, and vasoactive neuropeptides in the cardiovascular adaptation to exercise training in the elderly.